Sunflower Pediatric Clinical Trials (SPeCTr 3.0)

The purpose of the current proposal is to build on the success of the first two cycles of the ISPCTN in the state of Kansas with SPeCTr 3.0 (Sunflower Pediatric Clinical Trials 3.0) by maintaining and expanding our work as part of the Environmental Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials Network (ISPCTN). Our site has demonstrated a strong track record of proposing, developing, implementing, and publishing findings from multicenter trial protocols within the 5 ECHO focus areas: pre-, peri- and postnatal outcomes; upper and lower airways; obesity; neurodevelopment; and positive health. With the current project we aim to accomplish 3 aims: 1) To develop, conduct, and disseminate findings from multicenter clinical trials research, assuring the participation of children living in rural or medically-underserved communities in IDeA states; 2) To build pediatric clinical trial research capacity at the clinical site; and 3) To engage interested parties such as community members, nonprofit organizations, and professional societies to enhance ECHO ISPCTN clinical trial impact, transferability, rigor, and feasibility. With the current proposal we expand upon our previous work by adding an exciting new Special Interest Group (SIG) focused on Pediatric Clinical Trials for our region, by expanding the membership of our Scientific Oversight Committee to include the JUNTOS Center for Latino Health and the new Center for African American Health. We also strengthen our ECHO ISPCTN Onboarding and Clinical Trials Skills Development Plan and propose methodology (survey, interview) to strengthen our input from key stakeholders across our state. As one of the top producing sites in the ECHO ISPCTN and through the rigorous use of these enhanced scientific methods, we aim to significantly contribute to the ECHO ISPCTN aims of providing valid and generalizable answers to intervention research questions relevant to the health of children from rural or medically-underserved backgrounds.

Public health relevance
The purpose of the current proposal is to build on the success of the first two cycles of the ISPCTN in the state of Kansas with SPeCTr 3.0 (Sunflower Pediatric Clinical Trials 3.0) by maintaining and expanding our work as part of the Environmental Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials Network (ISPCTN).